The Mass Partnership for Community-Engaged Cancer Control Equity

ABSTRACT
The Massachusetts Partnership for Community-Engaged Cancer Control Equity (Mass PCECCE) builds
on a robust partnership between the Harvard T.H. Chan School of Public Health, the Massachusetts League of
Community Health Centers, and Mass General Brigham. The proposed Center is well-poised to further
accelerate community-academic collaborations to advance transformative solutions for cancer equity.
Our Center's theme is advancing cancer control equity by strengthening community health center's
(CHC) capacity to deliver evidence-based cancer screening and tobacco treatment and by promoting
social and digital connection among patients and their communities. Advancing cancer control equity will
result from CHC systems that deliver evidence-based care together with community organizations that support
community needs. The Partnership has selected four local priorities as SDOH targets: (1) social capital,
which reflect the resources embedded within social connections; (2) civic engagement, or the actions that a
community takes to improve its circumstances; (3) access to digital skills and technology (here forward
referred to as “digital access”), which impacts on equity in access to health care and social resources that
support health; and (4) access to evidence-based cancer control care for breast, cervical, and colorectal
cancer screening and tobacco treatment, reflecting Healthy People 2030 objectives. We will conduct a
multi-level intervention at 2 levels— the community level to build community social capital and civic
participation, enabling engagement that will improve resident access to health and economic resources, and
the systems level to improve cancer control care (e.g. cancer screening and tobacco treatment) and digital
access, by digital needs screening and navigation to needed resources.
To support the Center's goals and planned research, we will: (1) create a community-partnered approach to
conducting research and building both community and CHC capacity to address key SDOH through a strong
Admin Core; (2) create a process for developing and sustaining research that is responsive to community
interests through our Community Responsive Project (CRP) Program; and (3) create an innovative, centralized
approach for efficient collection, management, and sharing of research data across the Center through a data
ecosystem, and supporting the methodologic needs of the Center through a Research Methods, Measurement,
and Data Management Core. This is a highly integrated Center with a strong emphasis on capacity building for
all partners. We aim to link CHCs and communities in ways that maximize civic engagement and participation
in cancer control research and care to address health inequities, using approaches that are scalable and
sustainable across MA and nationally.

Public health relevance
NARRATIVE The Massachusetts Partnership for Community-Engaged Cancer Control Equity (Mass PCECCE) will focus on advancing cancer control equity by strengthening community health center's (CHC) capacity to deliver evidence-based cancer screening and tobacco treatment and by promoting social and digital connection among patients and their communities.